Motivational Enhancement and Device Support Interventions to Increase Continuous Positive Airway Pressure Therapy Adherence in Adults with Obstructive Sleep Apnea

PROJECT SUMMARY
Despite decades of research documenting the benefits of continuous positive airway pressure (CPAP) therapy,
this highly effective treatment is not initiated, implemented, or persistently used by the millions of adults
worldwide diagnosed with obstructive sleep apnea (OSA). An estimated 16% of patients refuse CPAP after a
single night’s use, 29-83% do not adhere to current CPAP recommendations, and up to 50% abandon CPAP
after one year. Untreated OSA is associated with a range of distressing symptoms, dangerous comorbid
conditions, billions in healthcare spending, and higher all-cause mortality. Growing evidence shows that older
adults, people with low socioeconomic status, and certain racial/ethnic minority groups are at higher risk for
developing OSA, less likely to adhere to CPAP therapy, and experience worse outcomes than other groups.
Other variables associated with CPAP non-adherence are commonly experienced CPAP side effects, knowledge
deficits, low levels of self-efficacy, motivation, and confidence, and fragmented healthcare delivery. A variety of
educational, supportive, behavioral, and mixed interventions have been tested in randomized controlled trials
(RCTs). While each of these intervention types has demonstrated efficacy to varying degrees, key knowledge
gaps remain as to: (1) which intervention type leads to the greatest improvements in long-term CPAP adherence
and clinical outcomes; (2) who benefits most from a given intervention; and (3) what duration and/or sequence
of interventions is required to effectively induce behavior change. Collectively, these gaps suggest the need for
the development and testing of adaptive interventions aimed at improving CPAP adherence. Adaptive
interventions capitalize on differences in how patients respond to intervention by providing appropriate
modifications for those who need them and when they need them. To our knowledge, no fully powered RCTs
have tested the effectiveness of adaptive interventions aimed at increasing CPAP adherence. Project objective:
is to evaluate a telehealth-delivered adaptive intervention for persons newly diagnosed with OSA that promotes
CPAP adherence and improves health outcomes and assess potential mediators and moderators of treatment
response. Aim 1: Compare effects of motivational enhancement, device support, and standard care on primary
and secondary outcomes at 3 mo. Aim 2: Determine which behavioral change treatment is most efficacious at
promoting primary and secondary outcomes in participants who respond and do not respond to initial treatment
at 6 and 12 mo. Aim 3. Assess if CPAP adherence is mediated by stage of change, self-efficacy, knowledge,
and/or confidence and moderated by social economic status, race, and sex at 3 mo. By using an innovative
adaptive design and telehealth-delivered approach, study results will directly lead to a more personalized
approach to increasing long-term CPAP adherence and improving health outcomes of persons with OSA while
simultaneously generating a better understanding of factors that drive CPAP adherence across a variety of
personal, social, and economic contextual factors.

Public health relevance
PROJECT NARRATIVE Despite decades of research documenting the benefits of continuous positive airway pressure (CPAP) therapy, this highly effective treatment is not initiated, implemented, or persistently used by the millions of adults worldwide diagnosed with obstructive sleep apnea (OSA) The overall objective of the proposed project is to evaluate a telehealth-delivered adaptive intervention for persons newly diagnosed with OSA that promotes CPAP adherence and improves health outcomes and assess potential mediators and moderators of treatment response. By using an innovative adaptive design and telehealth-delivered approach, study results will directly lead to a more personalized approach to increasing long-term CPAP adherence and improving health outcomes of persons with OSA while simultaneously generating a better understanding of factors that drive CPAP adherence across a variety of personal, social, and economic contextual factors.